Invasion Dynamics

Abstract: Project 3: Medical College of Wisconsin
Leptospirosis is the most widespread zoonotic disease worldwide, and varies in severity from mild illness to
fatal hemorrhagic disease with multiple organ failure. Since endothelial damage and increased vascular
permeability are prominent features of leptospirosis, we focus on identification of L. interrogans adhesins that
mediate attachment to human endothelial cells in culture, identification of endothelial cell receptors to which
the bacteria bind, and on the consequences of Leptospira-endothelial cell interaction on the integrity of the
endothelial layer. Pathogenic L. interrogans crosses endothelial layers (transendothelial migration) efficiently,
while the non-pathogenic L. biflexa does not. The major contributor to endothelial cell-cell adherens junctions
(AJs) and barrier function, VE-cadherin, is a receptor for L. interrogans, and L. interrogans causes disruption of
AJs, while L. biflexa does not. We identified two L. interrogans adhesins that bind to purified VE-cadherin with
high affinity. We will collaborate with the Pasteur and UCLA groups to assess phenotypes of existing
transposon mutant clones, as well as knock-in (gain of function) and knock-down mutants in cell culture and in
animal models to identify and better characterize Leptospira proteins that contribute to invasion of endothelial
barriers. In these experiments we will also generate samples for analyses of 1) bacterial and 2) host gene
expression, and 3) host response biomarker production in a relatively simple cell culture model. Datasets 2 and
3 will be compared to those generated by the Duke group to identify and characterize the responses generated
during human infection. Our hypothesis is that endothelial damage in leptospirosis results from collaboration
between bacterial virulence determinants and endothelial cell responses. Aim 1 will assess human endothelial
cell responses to, invasion dynamics, and in vivo tissue tropism of, diverse Leptospira isolates. Endothelial AJ
integrity and bacterial transendothelial migration will be compared after infection with clinical and
environmental isolates belonging to high-virulence and low-virulence pathogenic species, and saprophytic
species, at various times post-inoculation. Supernatants will be used to quantify cytokines and other potential
biomarkers of Leptospira infection. Cell layers and supernatants will be used for RNA-Seq to identify changes
in host and bacterial gene expression. Statistical analyses of associations between pathogenicity, endothelial
damage, and host responses will identify potential biomarkers as indicators of leptospirosis in patient blood
samples, which could inform improved diagnostics in conjunction with the results obtained by the Duke group.
Aim 2 will determine the roles of known and candidate L. interrogans adhesion proteins in adherence to, and
invasion of, endothelial cell layers. Some of the candidate adhesins of interest include a family of leucine-rich-
repeat (LRR) proteins identified by the Pasteur group, and notably, LRR proteins are over-represented in
highly pathogenic Leptospira genomes. Our work will establish ties between genome content, protein function,
and endothelial responses in endothelial damage in leptospirosis.